Early Intensive Behavioral Intervention for Autism

? DESCRIPTION (provided by applicant): We propose to study the long term outcome of Early Intensive Behavioral Intervention (EIBI) for children with autism spectrum disorder (ASD and to test promising predictors of outcome. We will follow up at age 14-15 71 children treated in the preschool years with EIBI in publicly funded community agencies and 65 children contemporaneously diagnosed with autism but who did not receive EIBI (Treatment as Usual, TAU). ABA intervention models such as EIBI have empirical support from many studies, but it remains important to assess their long term impact, particularly when delivered in community agencies, where most intervention is administered. Previous studies have evaluated outcome primarily with respect to IQ and academic functioning. Therefore, we will compare the outcome of EIBI and TAU with a comprehensive battery that includes measures of ASD symptoms, intellectual function, adaptive skills, social competence, language, academic achievement, and psychopathology. These variables not only have empirical support as being core and associated features of ASD, but are related to the skills acquired in EIBI. We expect children with EIBI to have better outcome than the TAU sample overall. We will use marginal structural models (MSMs) to examine group differences; MSM uses the probability of treatment selection as a weight to adjust for the bias in treatment selection, a technique known as the inverse probability weighting. Finally, noting the labor intensiveness and expense of EIBI, we will test pre-treatment predictor variables with some empirical support from prior studies by our research group and other investigators: social engagement and stereotypy. We will use multiple linear regression to test the hypothesized predictors. To improve robustness, we will use the generalized estimating equations (GEE) for inference. Identifying predictors of outcome of EIBI will permit therapists to avoid focusing on children unlikely to benefit from this treatment and facilitate future efforts to develop effective interventions for these children. The proposed study represents the longest follow-up of large EIBI and TAU samples, such that we would have a unique opportunity to examine long-term outcomes and the prediction of outcomes for EIBI.

Public health relevance
PUBLIC HEALTH RELEVANCE: Early intensive behavioral intervention (EIBI), which beings before age 5 and involves 15-40 hours per week of individualized treatment for >/=2 years, accelerates cognitive and academic development in children with ASD. Our project addresses the need to examine long-term outcomes of EIBI and to identify predictors of individual differences in outcome. It compares outcomes at age 14-15 years of children who received EIBI and children with ASD who received treatment as usual from publicly funded, community agencies.